DC Partnership for HIV/AIDS Progress (DC PFAP)

In its first 11 years, the program has successfully partnered with Alan Greenberg of the George Washington University School of Public Health and Health Policy and formed a network of the 15 largest HIV providers in the District of Columbia The project has created a common data base for the 15 providers, linking key HIV related information for patients being seen at all sites who agree to participate in the observational cohort that has been created. The DC Cohort is overseen by the DC PFAP Steering Committee but managed by Alan Greenberg, Amanda Castel, and Anne Munroe of GW School of Public Health. The Cohort now has more than 11,000 HIV positive volunteers among DC's 17000 persons with HIV. This is the largest urban HIV cohort in the nation. An increasing number of high quality publications are being produced. The cohort received 5 years of NIH funding in 2020, and Dr. Castel received her first cohort related R01 grant related to a cohort study on tobacco cessation. The DC PFAP Subspecialty Clinics were established as a distinct pillar of DC PFAP in order to address the increasing prevalence of medical co-morbidities that are affecting the health of people living with HIV/AIDS (PLWHA), targeting underinsured and disenfranchised populations. Medical co-morbidities have become a major concern among the PLWHA community as people are living longer with HIV infection as a direct result of improved antiretroviral medications. Unfortunately, morbidity and mortality rates have now become a result of problems such as liver disease, renal disease, cardiovascular disease, metabolic disorders and malignancies, which may be related to HIV, to concurrent infections, or to non-infectious co-morbidities. Since June 1, 2009, the Subspecialty Clinics have been created and the providers have started to engage patients in the medical care of hepatitis C viral infections. It is crucial to the DC PFAP mission that these programs become integral components of the health care community in DC, and embed their services within the existing community HIV and Primary care medical clinics. Over 1600 patients with HCV have been evaluated for studies at community-based sites. This program is the leading clinical research program in the US focusing on the development of new HCV therapeutics and the delivery of such drugs. DC PFAP leaders appear at many national meetings, and were founding leaders and members of the AASLD-IDSA national guidance on HCV Management, the gold standard for management in the US. The Program has also focused on the role of marginalized patients in propagating the epidemic. Clinical sites in northeast and southeast DC have been designed to assess the characteristics and molecular viral sequences of HIV and HCV in these populations, and compare them to new case isolates to determine which subgroups are most important regarding new cases of HIV and HCV. The GRAVITY study has enrolled 500 marginalized persons to determine their incidence and prevalence of HIV and HCV. Molecular epidemiologic analysis is underway to determine their link to new cases in DC. HCV therapy is very popular among persons with and without HIV in DC. Thus, providing access to such therapy is being assessed as a bridge to HIV services (ART and PREP) and to opioid use disorder services in protocols developed by Dr. Rosenthal Given the importance of opioid use disorder in contributing to risky behavior that promotes HIV and HCV transmission, and given the importance of opioid sue disorder in interfering with adherence to PREP and ART, DC PFAP has been funded by NIH OD to collaborate with pharmaceutical companies on the development of new strategies for dealing with OUD. This developing project is being performed with the Clinical Directors of NIDA, NIMH, NIAA, and NINDS. In 2019 a phase I study of ANS 6697 was completed at the CC to meet FDA requirements for drug development for a novel compound that reduces cravings. This study has been suspended due to hepatotoxicity of the lead compound and will resume if the sponsor can develop a molecule that targets the same dopamine pathway and does not have unacceptable toxicity In 2021 the project continues to focus on marginalized populations that are either not in care or not in effective care. These populations appear to be central to the continued low level incidence of HIV in Washington DC. The clinical operation has expanded focus on opioid use disorder and is completing a needs assessment with GW, University of Maryland, Emory and University of Alabama to determine what deficiencies are there in services for hospitalized patients with OUD related infectious complications in terms of both inpatient services and linkage to reliable outpatient services. A proposal has been submitted to HEAL for dealing with the deficiencies in services that are being documented. The proposal would assess the effects of improving those needed services on the acquisition and transmission of HIV, HCV and other infectious disease endpoints, as well as parameters of OUD disorders such as ER visits and overdoses and overdose deaths. The program has also established a clinic for transgender persons that will assess how to optimize HIV and HCV services for this group, with special emphasis on the effects of hormonal therapy on HPV, gut microbiome and HIV reservoir, depending on what funding is available